Signaling in the Microvasculature During Skeletal Muscle Regeneration

PROJECT SUMMARY/ABSTRACT
Studies into regeneration of damaged skeletal muscle via the resident stem cell population (satellite cells) in
the past 30 years have provided a wealth of knowledge regarding transcriptional, epigenetic, and signaling
influences on this process. However, given that muscle tissue is made up of multiple cell types that are
essential to its function, surprisingly little is currently known about regeneration of the vascular network that
exists physically alongside muscle fibers and is necessary for their physiological function, or of signaling
interactions between regenerating myofibers and their microvasculature. To address this gap in knowledge, the
Cornelison lab (with expertise in muscle regeneration and molecular signaling) and the Segal lab (with
expertise in vascular physiology) have been pursuing studies aimed at identifying molecular and physiological
interactions coordinating the repair of muscle and vessels after injury. This proposal will leverage the unique
and complementary strengths of both labs and will also develop and apply new 3D imaging and cell culture
techniques to advance this goal. Specifically, the applicant will 1) test the requirement for the juxtacrine
signaling molecule ephrin-B2 in microvessel regeneration following muscle injury; 2) test the hypothesis that
perturbed vessel regeneration will lead to perturbed muscle regeneration; and 3) identify key molecular
interactions between endothelial cells and myoblasts in a novel ex vivo system. These experiments will be the
first to investigate the role microvessel regeneration plays in muscle regeneration, and the first to examine the
role of Eph/ephrin signaling in microvessel regeneration in skeletal muscle. In the course of performing this
research, the applicant will receive training that spans physiological, cell biological, and molecular techniques
and their interpretations as well as experience in critical thinking, reading, and writing.

Public health relevance
Signaling in the Microvasculature During Skeletal Muscle Regeneration PROJECT NARRATIVE The interdependence of muscle and vessel regeneration and the signaling mechanisms that coordinate this regeneration is poorly understood but critical to both basic science and human health. A better understanding of the mechanisms guiding regeneration may lead to treatments that would accelerate or improve wound healing after injury. The knowledge gained through the proposed research will shift the focus in the fields of muscle biology and vascular physiology from viewing muscle and vessel regeneration as independent unrelated processes to a highly coordinated dual process functioning synergistically.